Cofactor metabolism and mitochondrial function in malaria parasites

Plasmodium parasites are responsible for hundreds of millions of malaria cases annually. During the asexual
stages of development in red blood cells, malaria parasites acquire certain nutrients from human serum while
retaining the ability to synthesize others. We are studying an essential enzyme cofactor called lipoate and its
metabolism in Plasmodium falciparum. Our studies demonstrate that erythrocytic stage parasites are
auxotrophic for lipoate, even though they contain a metabolic pathway to synthesize this cofactor. Proteins in
the apicoplast organelle rely on lipoate synthesis while proteins in the parasite mitochondrion rely on
scavenging and cannot obtain lipoate synthesized in the apicoplast. The proposed studies are focused on two
aspects of lipoate scavenging and employ a combination of biochemical, cell biology and genetic approaches.
Our first aim is to define the essentail roles of lipoate-dependent proteins and identify the factors required to
support these activities in the parasite mitochondrion. Our second aim will probe the mechanism of lipoate
uptake and attachment to mitochondrial proteins in order to understand how, when and why this process is
gated by redox potential. These studies will forge a detailed link between the lipoate attachment enzymes and
their protein substrates. By virtue of relying on a host nutrient, these proteins represent a vulnerable aspect of
parasite biology which could be targeted at several levels.

Public health relevance
The inevitable rise of drug-resistant malaria parasites creates a continuing need to develop new control strategies. Our research exploits the finding that malaria parasites depend on the host for an important enzyme cofactor. Understanding how the parasites obtain this cofactor and what they use it for will expose vulnerable aspects of parasite biology that could serve as avenues for new therapeutic interventions.